DP21-001 Component A [Core]: Massachusetts Pregnancy Risk Assessment Monitoring System (PRAMS)

PI / PD: Diop, Hafsatou RFA-DP-21-001
Project Summary/Abstract
The overall goal of the Massachusetts Pregnancy Risk Assessment Monitoring
System (PRAMS) is to collect data to improve the health of mothers in the
preconception, perinatal, or postpartum periods and the health of their infants.
Massachusetts (MA) has implemented PRAMS since 2007 and oversamples women by
race/ethnicity to allow women of color to have a greater opportunity to participate in the
survey. PRAMS methodology uses a mixed mode survey (mail and telephone) to inquire
about maternal attitudes, experiences and behaviors before, during and shortly after
pregnancy. There are approximately 70,000 births annually in MA, of which 2,400 are
sampled for inclusion in PRAMS. During the last three years for which we have weighted
data, the overall weighted response rate was 59.9%, 61.9%, and 62.4%, for 2016, 2017,
and 2018, respectively. MA PRAMS response rates have been consistently above the
CDC minimum response rate threshold of 55% during 2016-2018.
PRAMS will be used to inform the Title V priorities and performance measures,
and support MA maternal and child health (MCH) priorities. We propose to use PRAMS
to provide reliable data to inform MCH programs with limited or nonexistent data. For
example, although MA has taken a number of steps to understand and respond to the
opioid epidemic, data on prescription pain relievers and other opioids during pregnancy,
particularly among women who have not been diagnosed or treated for substance use
disorder were lacking, as they are not captured in administrative and program data. In
addition, data on whether women received substance use disorder treatment from
providers including medication-assisted treatment (MAT) during pregnancy were limited.
We will use the PRAMS Opioid Survey and Opioid Call-Back Survey (OCBS) to obtain
these data among new mothers. In addition, the OCBS will provide a unique opportunity
to ask about access to substance misuse treatment, including MAT, rehabilitation
services, and other programs such as peer-to-peer support systems, and to identify best
practices to mitigate the risk of opioid misuse in the postpartum period and reduce
maternal opioid misuse and overdose events. Similarly, in response to the current
pandemic, MA is also working on implementing a COVID-19 survey to better understand
the inequities we see in the spread and treatment of COVID-19.

Public health relevance
Project Narrative The mission of the Massachusetts Department of Public Health (MDPH) is to prevent illness, injury, and premature death, to assure access to high quality public health and health care services, and to promote wellness and health equity for all people in the Commonwealth. MDPH aims to provide timely access to data to reduce disparities and improve outcomes, address the social determinants of health which contribute to health inequities, and eliminate institutional and structural racism.The Massachusetts Pregnancy Risk Assessment Monitoring System (PRAMS) provides data on maternal experiences and behaviors before, during and shortly after pregnancy that can be used to inform and improve maternal and child health programs and policies, furthering the mission of MDPH and promoting the health of Massachusetts families.